Manganese dioxide as a nanozyme to mitigate oxidative stress in osteoarthritis

PROJECT SUMMARY
In this proposal, we aim to characterize the multi-enzymatic and chondroprotective functions of a
bioactive biomaterial, manganese dioxide (MnO2) nanoparticles (NPs), as a therapeutic strategy to
mitigate oxidative stress in osteoarthritis (OA). The motivation for this work is the critical need to address
limitations for treating OA as a looming public health crisis, projected to affect 130 million people worldwide by
2050 due to an aging population.
Oxidative stress, the imbalance between reactive oxygen species (ROS) generation and antioxidant
function, is known to contribute to OA progression and may represent an important therapeutic target. There
have been numerous studies to evaluate the use of antioxidants and small molecules as therapeutic agents,
however these therapies are limited by poor bioavailability and stability within the joint. The objective of this
proposal is to utilize a metal-oxide biomaterial (MnO2) to overcome limitations of retention and bioavailability
and seeks to explore enzyme-mimicking functions to reduce the effects of oxidative stress. We have previously
shown that MnO2 can be engineered with cartilage-targeting properties, such as size and charge, that can
overcome limitations of traditional antioxidant therapies. Leveraging these properties we have seen improved
retention of MnO2 NPs in healthy and OA joints. Due to the barriers for targeting cartilage, this advancement is
critical in the development of a chondroprotective therapy. We hypothesize that MnO2 NPs possess enzyme
mimicking properties that will reduce oxidative stress in the joint thereby alleviating pain and disease
pathogenesis.
Characterization of enzyme mimicking functions is critical in the use of MnO2 NPs for biomedical
applications and may further classify the biomaterial as a ‘nanozyme.’ Our lab has already characterized the
hydrogen peroxide scavenging properties of MnO2 NPs and we anticipate ‘nanozyme’ classification will outline
catalase-like, superoxide-like, and peroxidase-like functions of MnO2. In Aim 1, we will examine how MnO2 NPs
influence compartment specific H2O2 production and the downstream effects of oxidative stress. Specifically,
we will characterize the antioxidant-like properties of MnO2 NPs and their impact on redox signaling,
chondroprotection, and inflammatory effects. In Aim 2 we will evaluate the therapeutic efficacy of MnO2 NPs in
vivo using a rodent model of post traumatic OA (PTOA) through comprehensive evaluation of NP retention in
the joint, joint remodeling, and behavior. Immediate treatment following joint trauma, which leads to PTOA, is a
critical opportunity for translation of a cartilage targeting therapy by leveraging cartilage that is still intact and
may be responsive to mitigating oxidative stress. The proposed work is significant and innovative by revealing
key mechanisms for mitigating oxidative stress and advancing the use of an enzyme-mimicking therapy that
may facilitate translation of strategies to slow the progression of joint disease.

Public health relevance
PROJECT NARRATIVE Osteoarthritis (OA), the leading cause of disability in the United States, has no effective therapy to slow or prevent disease progression. Oxidative stress plays a central role in the development of OA, however attempts to mitigate oxidative stress with antioxidants have been limited by poor bioavailability and limited stability within the joint. Thus, the objective of this proposal is to utilize a cartilage-targeting nanomaterial with antioxidant-like properties that overcomes limitations of conventional therapies to effectively mitigate oxidative stress, thereby reducing damage to joint structure and preserving joint function in post traumatic OA.